miR-301b inhibits autophagy by directly targeting RAB5A

PROJECT SUMMARY
End-stage heart failure (HF) due to dilated cardiomyopathy (DCM) is the most common indication for cardiac
transplantations in children over the age of 1 year. Though DCM affects both adults and children the causes can
be different, with ischemic heart disease being the most frequent cause of HF in adults whereas in children the
most common cause of DCM is idiopathic. However, the therapeutic strategies in children with heart failure are
based on adult clinical studies and are less effective in managing HF in children. This suggests that
understanding the mechanisms of heart failure in children is critical to identify novel age-specific therapeutic
targets in this population and improve the translational barrier roadblock in pediatric DCM patients.
My preliminary data suggests that miR-301b is highly expressed in pediatric DCM hearts and its predicted target
genes are implicated in autophagy. In addition, primary cardiomyocytes over-expressing miR-301b demonstrate
inhibited phagosome formation associated with reduced RAB5A protein expression. RAB5A is known to be highly
expressed in the heart and is a miR-301b predicted target gene. In this application, I propose to determine the
expression level of autophagy-related proteins in the heart tissue of pediatric DCM patients (Aim1),
establish the effect of miR-301b over-expression on autophagy and apoptosis in primary cardiomyocytes
(Aim2) and Determine in vivo regulation of cardiac autophagy by miR-301b and its consequence on
cardiac function in neonatal mouse model. These studies will confirm the negative effect of miR-301b on
autophagy, apoptosis and most importantly on cardiac function by directly targeting Rab5A and contribute to the
development of novel age-specific therapies in children with heart failure addressing the translational barrier
roadblock in this population.

Public health relevance
Project Narrative Dilated Cardiomyopathy (DCM) is a disease that affects both adults and children with different etiologies. However, the therapeutic strategies in children with heart failure are based on adult clinical studies and are less effective in managing HF in children. The purpose of this study is to investigate the mechanistic role of miR-301b in regulating autophagy in cardiomyocytes and evaluate changes in autophagic markers in pediatric DCM hearts. This study underscores the importance of pediatric-focused research studies and is critical to identifying novel age-specific therapy in this group and improving the translational barrier roadblock that negatively affected pediatric heart failure patients.